The TENDAI study: Task shifting to treat depression and HIV medication nonadherence in low resource settings: Supplementary funding to fulfill the scope of work after Covid-19 delays

This application is being submitted to PA-20-272 in accordance with NOT-MH-21-120
Zimbabwe has the 5th highest prevalence of HIV globally. Depression is consistently and
significantly associated with worse adherence to antiretroviral therapy (ART). However,
evidence-based treatments for depression in people living with HIV are rarely available in
low-resource settings including Zimbabwe. To address the unmet need for scalable, low-cost
mental health care for people living with HIV, the parent grant is implementing and
evaluating the effectiveness of the TENDAI intervention. TENDAI is a task shifted
intervention for depression and ART adherence, suitable for delivery by non-specialists. The
effectiveness of the task shifted intervention is tested through a 2-arm parallel group
randomized clinical trial. Supplementary funding is requested to fulfil the scope of work
including collecting the primary outcome at 12 months post randomisation, after
unanticipated delays due to the COVID-19 pandemic.
Policies at all sites in response to the Covid-19 pandemic had a significant impact on
participant recruitment. Without 290 participants followed through to the 12-month post-
randomisation follow-up, we will not have the sample size to deliver on the project’s stated
scope of work. In this supplemental application, we propose to ensure a total of 290
participants are recruited, and all 12-month post- randomisation outcome measures are
collected. We will achieve this by ensuring sufficient staffing to accelerate recruitment,
collect all follow-up data, and conduct analyses for primary and secondary outcomes and the
economic evaluation manuscripts. We have implemented cost-saving strategies at all study
sites over the previous two years and can fund the bulk of this work with our unobligated
balance. We are requesting additional allocation of funds to successfully complete this
innovative clinical trial. The results from this trial have the potential to improve lives for
people living with HIV at the centre of the HIV epidemic, and to advance progress towards
the 95 95 95 goals.

Public health relevance
It is a priority to build an evidence base from within low-income African countries about whether improving mental health can bring about better HIV outcomes. Our parent grant aims to evaluate the effectiveness and cost-effectiveness of a task-shifted intervention for depression and non-adherence to HIV medication on adherence, depression, and viral suppression at 12-months follow-up. Due to Covid-19 related delays we are requesting additional allocation of funds to successfully complete this innovative clinical trial.